CSHL 2022 Neuronal Circuits Conference

Cold Spring Harbor Laboratory Conference on
Neuronal Circuits
MARCH 16 – 19, 2022
Project Summary
This proposal seeks support for the meeting on “Neuronal Circuits” to be held at Cold
Spring Harbor Laboratory March 16 – 19, 2022. The meeting will assemble leaders in the field,
together with junior faculty, postdoctoral fellows, and graduate students, that represent the
diversity of the scientific community, including underrepresented individuals. The participants
will discuss the latest advances that analyze the organization and function of nervous systems
on the level of neuronal circuits in a variety of systems and species.
The remarkable computational capacity of neuronal circuits remains a major unresolved
problem in biology, serving as the core substrate linking genes and behavior. We believe that
the magnitude of this problem requires communal efforts among scientists working on different
organisms and systems. Creating such synergy served as a motivation for starting this biannual
meeting series. Almost two decades later, this meeting has emerged as a well-established and
highly regarded forum for the neuroscience community, which has an unusual inter-species
flavor and focus on circuit structure and function. By its very nature, research presented in the
meeting is highly interdisciplinary as it brings together experimentalists, theorists, and
researchers from a range of quantitative disciplines.
The 2022 meeting relies on the notion that behavior is the essential and ultimate output
of the cognitive and computational processes in neuronal circuits. Sessions are therefore
organized around different aspects of cognition and behavior and their neuronal
representations, including topics on decision-making, navigation, vocal communication, motor
learning, and social interactions. Further sessions on circuit plasticity and the newest
approaches to investigate large-scale neural coding will round up the program. Each session
will be chaired by a leading scientist in the field. Oral presentations will be given by
distinguished invited speakers, pairing established investigators with talented junior faculty that
are rising stars of their sub-disciplines, as well as by speakers selected from submitted
abstracts by a steering committee comprised of the invited speakers. Selected speakers will
include graduate students, postdoctoral fellows, and junior faculty, with the aim of maximal
inclusion of young investigators and under-represented individuals. Of special importance are
the two poster sessions, where many participants can present their work in an atmosphere
conducive to informal discussion. The meeting will be of moderate size and we expect about
250 people to attend, the vast majority of whom will be presenting a poster or talk. To account
for the remaining uncertainties of the current COVID-19 pandemic and eventual travel
restrictions that might still apply in 2022 in some countries, the oral sessions will be made
available online and a certain contingent of registrants can sign-up for a virtual version of the
meeting.

Public health relevance
NEURONAL CIRCUITS Project Narrative The human brain possesses astonishing computational abilities. However, unlike computers, whose operations can be understood using wiring diagrams and defined logical algorithms, no similar circuit-level framework for the brain is available. What elementary circuit computations are performed by individual neurons, local circuits and entire neuronal networks? What are the molecular mechanisms that implement these computations? How much information does the wiring diagram contain? What other information is necessary to describe behavior? What physiological and genetic methods can provide such information? And what coding principles are used by large-scale neural networks? Traditionally, the basic operating principles of the nervous system have been derived from addressing these questions in a small number of model organisms and systems. Yet, to glean general principles of neural circuit computation that transcend the idiosyncrasies of any single organisms requires discussion of the similarities and differences to these answers across diverse members of the animal kingdom. Researchers working on different models will therefore benefit by exchanging their results and insights. To provide a venue for such interaction and exchange, we propose to hold a meeting entitled Neuronal Circuits at Cold Spring Harbor Laboratory in March 2022. This meeting will bring together experimentalists working on a diverse array of organisms, theorists, and researchers from a range of quantitative disciplines to discuss cutting edge approaches and findings in this field.